Loss of Bladder Control Following Recurrent Infections

Current estimates for the annual treatment of UTIs in the US including recurrences and their
complications exceed $3.5 billion. A significant number of UTIs are recurrent (recUTIs), with the
same subject experiencing multiple bouts of infection. A frequent outcome of recUTIs is loss in
bladder control which is manifested as increased urgency and frequency accompanied by loss
of bladder capacity. In spite of the severe discomfort and anxiety associated with this condition,
the underlying basis for bladder impairment has remained unresolved. In an experimental
mouse model of UPEC-­induced recUTIs, we observed exuberant sprouting of sensory and
sympathetic nerves was observed in the mouse bladder, which closely paralleled increased
bladder frequency and reduced bladder capacity in the infected mice. These observations
suggest that bladder nerve fibers actively respond to bacterial infections and these responses
could potentially contribute to loss of bladder dysfunction. Since a known determinant of nerve
cells sprouting in the bladder is nerve growth factor (NGF) we looked for possible sources of this
growth factor. We have identified mast cells (MCs) and monocytes as putative cellular sources
of NGF as mice subjected to recUTIs contain large number of recruited monocytes compared to
naïve mice and MC deficient mice do not any loss of bladder control even after recUTIs.
Therefore, we hypothesize that the loss of bladder control after recUTIs, is the direct result of
nerve fiber hyperplasia which is induced by NGF and other neurotrophic factors produced by
local MCs and MC recruited monocytes. We further hypothesize that it is possible to prevent
loss of bladder control in mice subjected to recUTIs by therapeutic targeting of NGF and other
neurotrophic factors. To validate these notions, we have proposed the following specific aims: (i)
Establish a clear link between neuronal sprouting and loss of bladder control in mice subjected
to recUTIs;; (iii) Examine the role of neurotrophic factors in bladder dysfunction following recUTIs
and the effect of targeting these factors to protect and even reverse bladder dysfunction (iii)
Investigate the contribution of MCs to neuronal sprouting and bladder impairment.

Public health relevance
The underlying basis for the loss of bladder control associated with recurrent urinary tract infection remains unknown. Here we plan to investigate if this loss in bladder function is due to exuberant outgrowth of nerve fibers and if inhibiting this nerve growth has any therapeutic potential.